Administrative Core

Project Summary/Abstract: Administrative Core
The Administrative Core of the Indiana Alcohol Research Center (IARC) provides leadership by coordinating
and optimizing the synergy of the interacting components and cores. The Administrative Core also provides
financial oversight and administrative support, and satisfies the critical need for the central management of a
complex budget spanning two schools at Indiana University (Medicine at IU and Science at IUPUI), their
different departments, and collaborations between Indiana University and Purdue University. The objective
and long-term goal of the Administrative Core is the smooth financial management of the grant budget as
proposed in this application, in addition to the coordination and integration of the scientific activities of the
participants and our collaborators. The rationale for including administrative support from Dr. Kareken’s office
in the Department of Neurology is to link the activities of the Center with the broader resources of Research
Administration and financial management support from Neuroscience Administration (program manager Tyler
Childress), where Neurology resides. The expected outcomes of the activities of this Core are the continued
excellence of the science and the coordinated, thematic, and collaborative activities of the Center. The aims of
the Administrative Core are therefore to: (1) Provide the scientific leadership, administrative support, and
ongoing annual financial oversight for the Indiana Alcohol Research Center. (2) (a) Assist in the identification,
recruitment, and development of new investigators in alcohol-related research, b) aid new investigators and
their applications for grants, c) help facilitate medical and graduate student exposure to alcohol research, and
d) maintain oversight of the web site to serve as a source of information for alcohol researchers, patients and
practitioners, and as a link to the Information Dissemination Core. (3) Provide leadership in organizing
seminars, conferences, and workshops, and in the dissemination of new research findings to the academic and
lay communities. (4) Foster collaborative research ventures between the IARC, other ARCs, and other
investigators both domestically and abroad.